Yale Head and Neck Cancer SPORE: Overcoming Treatment Resistance in Head and Neck Cancer

ABSTRACT (Parent Award): Head and neck squamous cell carcinoma (HNSCC) is the seventh most
common cancer globally. Current treatments are morbid, even for patients who are cured, and there are over
13,000 deaths in the US from HNSCC annually. HPV-negative HNSCC is commonly resistant to DNA
damaging therapy, EGFR inhibition and immunotherapy. HPV-associated tumors are highly treatment-
responsive, but 20-30 percent recur. Even with immune checkpoint inhibition, the majority of these patients
succumb. The Yale Head and Neck SPORE (YHNSPORE) represents highly translational researchers with
deep disease-based expertise who leverage the extraordinary scientific strength at Yale Cancer Center, to
improve treatment for patients with this terrible malignancy. YHN-SPORE investigators have significantly
impacted the field of HNSCC through training, and translational and clinical research. Basic scientists bring
rigorous methodology to bear. The YHN-SPORE seeks to address critical barriers to cure of HNSCC due to
resistance to immune, DNA damaging and targeted therapy through these specific aims: Aim 1: To overcome
resistance to EGFR inhibition in HNSCC by targeting active conformations of ErbB family members; Aim 2: To
advance rational synthetic lethal combination therapy to the clinic in HPV-negative HNSCC; Aim 3: To advance
combination demethylating therapy with immune checkpoint inhibition to the clinic for HPV-mediated HNSCC,
with mechanistic studies and characterization of immune response; Aim 4: To bolster the foundation for
HNSCC research through our Administrative, Biospecimen and Biostatistics/Bioinformatics cores, to engage
institutional resources and the wider SPORE community; and Aim 5: To advance new research and to foster
the next generation of HNSCC translational researchers through a Developmental Research Program, a
Career Enhancement Program, and interaction and collaboration with the wider SPORE and HNSCC research
communities. The overarching theme of the 3 coordinated projects is overcoming treatment resistance,
spanning mechanistic insights into resistance to current treatment modalities and immunotherapy; translational
validation; human endpoints to underpin future trials of novel strategies to circumvent resistance; mechanistic
confirmation in correlative studies; and clinical trials in HPV-negative and HPV-driven HNSCC. Anticipated
translational outcomes of the YHN-SPORE are: (1) conformationally sensitive inhibitors to overcome
resistance to EGFR inhibition in HNSCC; (2) clinical safety and pharmacodynamic data combined aurora A
kinase/WEE1 inhibition in HPV-negative HNSCC; (3) proof-ofconcept and immunoprofiling data to support
development of combined demethylation and immunotherapy in HPV-mediated HNSCC; (4) novel models and
genomically-characterized tumors to enable HNSCC translational research; and (5) a diverse group of young
investigators who will emerge as the generation who cure HNSCC.

Public health relevance
NARRATIVE (Parent Award): The Yale Head and Neck SPORE is a team of clinical and laboratory researchers studying the problem of treatment resistance in head and neck cancer. Each of three projects brings a basic and clinical research leader together to study ways to overcome resistance to common therapies, such as cetuximab and cisplatin, as well as to find ways to make HPV-driven cancers more sensitive to immunotherapy; There are clinical trials to treat patients with HPV-negative and HPV-driven cancer before they go to surgery. The projects are supported by core facilities to provide administrative, pathology and statistical support, and there are funds to support new projects and new investigators.